Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The primary function of the administrative core of this P01 application will be to facilitate generation of scientific
knowledge by the three projects through efficient scientific progress, oversight and quality control of data,
dissemination of this knowledge through publications, our dedicated website (UWPKDAP), and conference
presentations, training of graduate students and postdoctoral fellows, and, where applicable, translation of this
new knowledge into clinical research. As indicated in the overview, the scientific focus of this application will
be generation of new knowledge on “Pharmacology of drugs of abuse during pregnancy.” To accomplish the
above stated primary function, the administrative core will have the following Specific Aims:
1. Ensure that the necessary administrative structure is in place for a) efficient scientific progress, oversight
and quality control of data (including rigor and reproducibility); b) collaboration and sharing of data within and
among the projects; c) rapid publication and dissemination of data; and d) training of graduate students and
postdoctoral fellows.
2. Ensure that appropriate administrative and fiscal oversight exists to allow attainment of goals stated in (1)
above.